Immune Regulation of the Blood-Brain Barrier

PROJECT SUMMARY
The overarching goal of this project is to understand the mechanisms underlying brain-immune interactions at
the blood-brain barrier and thereby generate novel targets for immunotherapy in neuroinflammatory conditions.
To achieve this goal, I will use an innovative approach that combines genetic manipulation of the brain vascular
endothelium in an animal model of viral encephalitis, creating an atlas of immune signaling at the blood-brain
barrier, and validation in human tissue. This project will address how inflammatory signals coming from the brain
parenchyma are translated across the blood-brain barrier endothelium, and where along the brain vasculature
these important immune interactions are occurring. A fundamental understanding of the mechanisms underlying
immune cell recruitment to the brain will open the door to novel therapeutics that specifically target immune
signaling pathways in the brain.
In completing this project, I will gain the critical training and skills necessary to fill the gaps in my current skill set
as I transition to an independent investigator. The training goals in this proposal have been carefully crafted to
form the foundation for a successful career in basic and translational scientific investigation in neurobiology,
immunology, and virology. This plan includes developing expertise in immunophenotyping, single-nucleus and
single-cell sequencing, animal models of disease, mouse genetics, and human tissue assays. My training plan
also includes specific resources, mentorship, and courses to support my career development as a physician-
scientist. To achieve these goals, I have assembled an outstanding mentorship team with scientific expertise in
complementary aspects of this project and exemplary track records for training independent investigators and
physician-scientists. In addition to my primary mentor Dr. Chenghua Gu, Dr. von Andrian will provide mentorship
in vascular biology and immunology. Dr. Quintana will complement these areas of expertise with mentorship in
innate immunology, neurobiology, RNA sequencing, and animal models of neuroinflammation. Dr. Knipe will
provide expertise in innate immunology and virology, and Dr. Chitnis will continue her outstanding mentorship in
human tissue studies and career development as a successful physician-scientist. The institutional resources
available through Harvard Medical School and Brigham and Women’s Hospital are world-class and will support
my career in an environment that fosters high-impact contributions and interdisciplinary collaborations. Through
this comprehensive training plan and carefully selected mentorship team, I will be ideally positioned to be an
independent investigator with a unique expertise in the brain-immune interface.

Public health relevance
PROJECT NARRATIVE This project seeks to understand the mechanisms of immune signaling at the blood-brain barrier during neuroinflammation in both animal models of disease and human tissue. The general approach combines the power of a novel model of viral encephalitis, brain vasculature-specific genetic manipulation, and thorough validation in human cases of viral encephalitis. The long-term goal of this research is to generate novel therapeutic targets at the blood-brain barrier to treat the millions of Americans who suffer from neuroinflammatory conditions including viral infection, autoimmune encephalitis, and multiple sclerosis.